Administration

CORE C. ADMINISTRATION AND MANAGEMENT A. Specific Aims The goals of this core are to facilitate the scientific mission of the center in a way that is maximally responsive to the needs of our research and technical personnel. Its specific aims are: 1. Provide administrative coordination of the overall research effort. 2. Facilitate interactions with MLPCN staff and investigators. 3. Manage budget and personnel issues related to the KU CMLD center.